EFFECT OF INTERFERON ON ANTIPYRINE METABOLISM IN MAN

Previous studies indicate that interferon inhibits hepatic drug metabolism. The purpose of this study is to determine the effects of recombinant human interferon alpha-2b on hepatic cytochrome P- 450-mediated drug metabolism by investigating the effects of interferon alpha-2b on antipyrine pharmacokinetics and metabolite excretion.